Trends in Severe Maternal Morbidity resulting from Pregnancy Loss

Project Summary/Abstract
Poor maternal health in the United States is a cause of increasing alarm. The rate of severe maternal morbidity
is high and has been increasing. However, the research into severe maternal morbidity does not consider
morbidity related to pregnancy loss. Pregnancy loss (ectopic pregnancy, miscarriage, or stillbirth) can be a
serious medical event, and adequate medical care during loss is essential to the health and wellbeing of
pregnant people. However, abortion bans may impact treatment and health outcomes for people experiencing
pregnancy loss. Since the Supreme Court overturned Roe v Wade with the Dobbs v Jackson decision in June
2022, 14 states, including Texas, have banned abortion with limited exceptions. Denials of and delays in
providing pregnancy loss care have been reported in states with abortion bans, jeopardizing women's
health. In addition to a total abortion ban implemented August 25th, 2022, Texas implemented SB8 on
September 1st, 2021, banning abortion after the detection of fetal cardiac activity.
I will use de-identified inpatient, outpatient, and emergency department data from Texas hospitals and
surgery centers for 2017 through 2024 to quantify severe pregnancy loss morbidity generally, and disparities
by race and ethnicity, maternal age, and insurance payer. Measuring severe pregnancy loss morbidity will
reveal opportunities to improve previously invisible aspects of pregnancy health. I will then assess changes in
the volume of pregnancy loss cases at Texas facilities and severe pregnancy loss morbidity after
implementation of restrictive abortion policies. I will disaggregate the data by subgroups to identify differential
impacts of the policies by race, insurance payer, and maternal age. Assessing the impact of abortion bans on
pregnancy loss case volume and morbidity provides policy relevant information on how reproductive health and
abortion policies affect women’s health.

Public health relevance
Project Narrative Poor maternal health in the United States is a cause of increasing alarm, but the research on severe maternal morbidity does not consider morbidity experienced during or after pregnancy loss. Recent restrictive reproductive health policies may be impacting treatment, care-seeking, and health outcomes for people experiencing pregnancy loss- a potentially serious medical event during which adequate healthcare is essential to health and wellbeing. This research quantifies severe morbidity experienced during pregnancy loss in Texas and assesses changes in hospital-based pregnancy loss care-seeking and severe morbidity experienced during pregnancy loss after restrictive reproductive health policies were implemented in Texas.